Bacterial quorum sensing

PROJECT SUMMARY
Quorum sensing (QS) is a form of cell-cell communication that allows members of a population to coordinate
cooperative activities in a cell density-dependent fashion. I am interested in bacterial QS control of cooperative
activities at a chemical, cellular and molecular level for three reasons. (I) Bacteria such as our main model,
Pseudomonas aeruginosa are ideal for studies of basic biological principles that underlie sociality. (II) It has
become clear that if we seek to understand bacterial communities, social interactions must be considered. (III)
There is an idea that QS and QS control of social activities in bacteria can serve as anti-bacterial virulence
therapeutic targets. I specifically focus on the acyl-homoserine lactone-LuxI-type signal generator/LuxR-type
signal responsive transcription factor pairs. My interests revolve around basic QS mechanisms, the selective
pressures favoring QS control of gene expression, and the costs and benefits of QS in bacteria. It is clear that
cooperativity is an evolved biological phenomenon, but there is considerable controversy about the selective
forces allowing stable cooperativity. What are the costs and benefits of cooperativity, and what are the possible
advantages to controlling cooperativity by QS? In the past ten years we have made enormous advances in
understanding at a molecular level how cooperation is stabilized in P. aeruginosa and how we can destabilize it.
These advances are important to the field of population biology and to our understanding of the roles P.
aeruginosa QS plays in certain infections. Our continued research will use molecular genetic approaches to
investigate QS control of gene expression, and we will continue to introduce new techniques and concepts into
what has become a vibrant field of microbiological research. I believe we are now in position to address
fundamental questions about evolution of QS signal diversity by continued studies of pure cultures of P.
aeruginosa. We also plan to expand our efforts to consider species-specific QS in polymicrobial communities by
developing an understanding of acyl-homoserine lactone QS in the context of the human intestinal microbiome.
Our research is fundamental to efforts aimed at manipulating QS during infections or in complex microbial
communities, and for biotechnological applications. We aim to better understand the role of QS during human
infections and as it relates to microbiome activity in human health and disease. My long-term vision is: I. To
understand how the diversity of QS systems has evolved, II. To attain a conceptual framework to explain how
communication and cooperative activities are wired to provide stability of bacterial group activities and how we
might be able to use the knowledge to manipulate bacterial populations. III. To gain insights about intraspecific
cooperation in the context of a complex multispecies microbial community.

Public health relevance
PROJECT NARRATIVE Quorum sensing has emerged as an active research area, which holds promise for development of novel anti- virulence therapeutics and manipulation of human microbiota to encourage health and discourage disease. The promise will rely on deep understanding of fundamental aspects of quorum sensing and bacterial social evolution. This proposal aims to deepen our understanding of quorum sensing and provide foundational information for development of therapeutic and other applications by 1- using the human pathogen Pseudomonas aeruginosa as a model to better understand the evolution of acyl-homoserine lactone quorum sensing, and 2- investigating acyl-homoserine lactone quorum sensing in the human intestinal tract.